MERRIT: Multidisciplinary Engineering and Renal Research for Innovation of Technology

PROJECT SUMMARY
Trainees with engineering and technological backgrounds have been traditionally underrepresented in the
kidney research field. We propose a new research educational program entitled MERRIT: Multidisciplinary
Engineering and Renal Research for Innovation of Technology as a joint venture between Mount Sinai Division
of Nephrology and Cooper Union School of Engineering. Our program will have three major foci: (1) building
sustainable awareness of clinical and patient needs in the kidney field among engineering trainees; (2) creating
innovative team-based and individual research experiences for undergraduate and graduate engineering
students; and (3) organize and disseminate pedagogical and educational lessons from the program through
web and media such that other institutions can develop similar programs successfully. We have assembled a
mentoring team comprising physician scientists and transplant nephrologists and basic scientists in the kidney
field as well as engineering faculty from electrical, mechanical and chemical engineering departments.
Mentors with complementary skills from the two institutions will supervise patient-centered student-initiated
design projects as well investigator-initiated individual kidney research projects. Through achievement of our
aims, we will generate a sustainable pipeline for training of future kidney researchers and nephrologists that
have a solid engineering background.

Public health relevance
PROJECT NARRATIVE We are proposing to create a new educational initiative titled MERRIT: Multidisciplinary Engineering and Renal Research for Innovation of Technology. The joint program between Mount Sinai and Cooper Union aims to bring together nephrology and engineering mentors from the two institutions to supervise patient-centered design teams and individual research projects on kidney disease.